Washington State Food Safety Surveillance Project

1 WASHINGTON STATE FOOD SAFETY SURVEILLANCE PROJECT
2 Abstract
3 The Washington State Department of Health Public Health Laboratories (WAPHL) is proposing
4 multiple projects through this cooperative agreement that will benefit from the strong
5 collaboration between the Microbiology and the Environmental Laboratory Sciences
6 Departments. Projects proposed in this application span two disciplines for which funding is
7 available. The proposed projects will build on FDA investments in WAPHL capabilities in the
8 areas of Food Microbiology, Advanced Molecular Detection and Food Radiochemistry.
9 The projects being proposed by the WAPHL will be accomplished through the inner workings of
10 having a well-established organizational structure, management style, quality assurance
11 program, subject matter experts, a solid laboratory infrastructure, established sample collection
12 relationships, and long lived collaborations.
13 WAPHL have been managing grants successfully for over 25 years. Among these, multiple
14 United States Food and Drug Administration (FDA), Environmental Protection Agency (EPA)
15 and Center for Disease Control and Prevention (CDC) grants have been funded. Currently the
16 WAPHL proposal includes projects that will be managed by the microbiology and the
17 environmental laboratory sciences departments. The laboratory has sufficient, equipment, and
18 personnel to support all of the projects proposed in this application. The laboratory also boasts
19 ISO accreditation for some of its radiation chemistry activities, has plans for expanding ISO
20 accreditation and has a robust and mature quality management plan for sections not covered
21 under ISO accreditation. The environmental sciences and microbiology sections also have
22 strong collaborations with several environmental programs within Washington State Department
23 of Health.
24 The collaboration within the WAPHL is a holistic approach by our Environmental Laboratory
25 Science and Microbiology departments here at WAPHL to work together in helping to create a
26 safer food supply for not only Washington State residents but also for visitors and other
27 consumers of Washington’s extensive food supply, and through the Food Emergency Response
28 Network (FERN), for the United States as a whole.

Public health relevance
PROJECT TITLE: WASHINGTON STATE FOOD SAFETY SURVEILLANCE PROJECT Overall Component. Project Start Date: July 1, 2025. Project End Date: June 30, 2030. Washington State Public Health Laboratories (WAPHL) is proposing multiple projects through this cooperative agreement that will benefit from the strong collaboration between the Offices of Microbiology and Environmental Laboratory Sciences. The projects proposed in this application span two of the disciplines for which funding is available. The proposed projects will either maintain or expand WAPHL capabilities in the areas of Food Microbiology, Advanced Molecular Detection, and Analytical Radiochemistry. The projects being proposed by laboratories within the WAPHL will be accomplished by leveraging well-established organizational structure, management style, quality assurance program, subject matter experts, a solid laboratory infrastructure, established sample collection relationships, and long-lived collaborations.